Identification, Surveillance, and Control of Vector-Borne and Zoonotic Infectious Diseases in Uganda

Project Abstract: While outbreaks of new, exotic infectious diseases, as well as the resurgence of old killer
diseases, have surfaced all over the globe in the past decades, no continent has been harder hit than Africa.
Sub-Saharan Africa is among the most affected region and is often referred to as the “Infectious Continent.”
Africa is faced with the greatest burden of old and new infectious diseases, and yet it has very low levels of
resource to manage them. Uganda, like much of sub-Saharan Africa, has had numerous highly infectious
disease outbreaks occurring concurrently or in very quick succession over the past few years. Presently,
there is an outbreak of Crimean Congo Hemorrhagic Fever virus infection among people. Over 15 cases
have been diagnosed in the past few months. In the past 2 years, Uganda has been experiencing Rift Valley
Fever Virus outbreaks together with Yellow Fever virus and Marburg virus outbreaks. There is need for
precise and effective targeting of resources, where laboratory disease detection, identification, monitoring,
risk mapping and assessment systems are put in place as the best strategy to stop disease spread at an
early stage or preventing them altogether. The aim of this proposal is to describe a multiyear project
investigating and controlling vector-borne and zoonotic disease in Uganda. Our proposal is to improve and
maintain an effective, coordinated program of diagnostics and surveillance of vector-borne infections and
High Hazard Hemorrhagic Fever Viruses to collect data and information on the diseases, vectors and
reservoir systems, ensuring prompt recognition and confirmation of disease outbreaks which would enable
action to be taken before the diseases have affected many people, thereby reducing morbidity and mortality.
We aim to investigate, characterize and control environmental and faunal aspects of filovirus outbreaks in
Uganda and neighboring countries. In under-resourced countries, like Uganda, the impact of infectious
diseases is often devastating - decreasing survival rates, particularly among children, and impeding
opportunities for economic growth and development. Ultimately, national surveillance systems need to be
strong enough to provide not only constant alert and rapid response to outbreaks of known endemic
diseases, but also ready to respond to a sudden unexpected outbreak of an unknown disease. Early
detection of diseases, through improved laboratory and field surveillance, new diagnostic tools, risk mapping,
and continued monitoring as envisaged in this proposal will assist to alleviate poverty, suffering and death of
the Ugandans due to zoonotic and vector-borne diseases. In this proposal we are requesting for assistance
of in funding of US $ 2,999,978.00 to sustain and improve systems of surveillance and detection of diseases
to reduce morbidity and mortality in affected people as well as reduce spread of the diseases to other areas.
This proposal will be a collaboration of the Uganda Virus Research Institute (UVRI), together with different
Branches of the US Centers for Diseases Control and Prevention, USA.

Public health relevance
Project Narrative This project will benefit the people of Uganda by improving the surveillance system for vector- borne and zoonotic diseases, thereby reducing the morbidity and mortality associated with these diseases, investing in the health infrastructure of Uganda, educating and training public health officials and the public on surveillance and control of these diseases, investing in academic development and capacity building for Uganda’s Research Institutions, Universities and the Ministry of Health. We aim to improve and maintain effective, coordinated programs of diagnostics and surveillance of vector-borne infections and High Hazard Hemorrhagic Fever Viruses to collect data and information on the diseases, vectors and reservoir systems, ensuring prompt recognition and confirmation of disease outbreaks which would enable action to be taken before the diseases have affected many people, thereby reducing morbidity and mortality by designing, evaluating and disseminating economically sustainable control strategies based on scientific knowledge gained from investigating the host, vector and pathogen epidemiology and ecology, the associated environmental and human behavioral risk factors, accurate and laboratory-based case surveillance and confirmation, pathogen microbiology and clinical treatment. We aim to investigate, characterize and control environmental and faunal aspects of filovirus outbreaks in Uganda and neighboring countries including 1) identifying those reservoirs which support the maintenance of filoviruses in nature, 2) determining the environmental factors which facilitate their spread, 3) strengthening of the capability within Uganda to more rapidly detect hemorrhagic fever outbreaks, and 4) development of better educational materials to enhance hemorrhagic fever awareness among the population.